Development of Quantitative Deuterium MRS Imaging for Human Brain Tumor Application at Ultrahigh Field

PROJECT SUMMARY
Glioblastoma (GBM) is the most aggressive form of human cancers with very high fatality rate and short
survival time, and the cancer cells aggressively infiltrate the brain and are intrinsically resistant to
chemotherapy and radiation therapy. Intra-tumoral heterogeneity is a major challenge in therapeutic
development for GBM patients because surgical acquisition of clinical specimens cannot be used to monitor
the tumor progression and/or the underlying metabolic changes. Various neuroimaging methods have been
used to study the morphology of the brain tumors. However, the need for noninvasively characterizing the brain
tumors and their metabolic features has not been met, which should be critical for prognosis or for monitoring
the tumor progression and response to treatment. It is well known that a common hallmark of the cancer cells
is disrupted glucose metabolism, in which upregulated glycolysis is accompanied by inhibited mitochondrial
oxidation, i.e., the “Warburg effect”. Imaging the “Warburg effect” and its spatial variability in brain tumors is a
new attempt that can have a major impact on cancer research, particularly in the treatment of GBM, because
therapies aimed at reversing the Warburg effect have shown promise in GBM ; however, great efforts are
needed to develop novel metabolic imaging techniques to achieve the capabilities sought by clinicians.
We have recently initiated a project aiming to develop a neuroimaging technique based on deuterium (2H)
MRS (DMRS) detection of 2H-labeled brain metabolites following an administration of D-Glucose-6,6-d2 (d66).
Our preliminary results indicate that the dynamic DMRS imaging can determine the cerebral metabolic rates of
glucose (CMRGlc) and TCA cycle (VTCA), thus, the lactate production rate (CMRLac) in addition to the
concentrations of deuterium-labeled glucose (Glc), mixed glutamate/glutamine (Glx) and lactate (Lac) in living
brains. Furthermore, we demonstrated for the first time that the uncoupling between the glycolysis and
oxidation in brain tumor can be quantitatively imaged via mapping the [Lac]/[Glx] ratio defined as an index of
Warburg effect (IWE); and it has been shown that IWE is highly sensitive for distinguishing brain tumor from
surrounding normal tissues. In this application, we are seeking NIH funding support to move forward with the
DMRS imaging development through: i) integrated hardware and software development and the ultrahigh field
MR technology to further boost signal-to-noise ratio (SNR), spectral resolution and spatiotemporal resolution; ii)
testing the ultrahigh resolution DMRS imaging in healthy subject, and tumor patients and establishing a
quantification model and imaging processing pipeline for future application; and iii) comparing the DMRS
imaging results with the neuropathological and immunohistochemical findings of the biospecimens to
understand the correlation between the DMRSI measurements and biological features of brain tumor. Our
interdisciplinary research team with unique expertise is ready for a full-scale development of this highly
innovative and cost-effective neuroimaging essential for basic research and clinic application in neuro-oncology.

Public health relevance
PROJECT NARRATIVE This project aims to develop and validate a novel metabolic imaging technique based on the in vivo deuterium magnetic resonance spectroscopy (DMRS) approach for quantitative assessment of one key brain tumor hallmark, termed the “Warburg effect” with high sensitivity, specificity and unprecedent spatial resolution. The success of the project will provide an innovative, noninvasive and cost-effective neuroimaging tool for improving clinical diagnosis and treatment management of brain tumor patients and other diseases.